A Systems Approach to Improve Safe Medication Management for Children with Medical Complexity

PROJECT SUMMARY
The proposed research addresses a key patient safety gap among children with medical complexity (CMC)
transitioning between hospital and home—medication related harm. CMC are often on multiple and complex
medication regimens and have intensive healthcare needs. As a result, they experience frequent transitions of
care, across professional roles and care settings and during these transitions, CMC are at great risk for
medication-related harm. Most transitional care interventions have been adopted from adult care settings and
may not be adequate to address the unique needs of CMC and their family caregivers. Interventions that are
grounded in the unique situations and complexities of such patients are needed to improve medication use
safety and family experience of care.
This proposal describes the PI’s plan to transition into an independent investigator by developing expertise in
1) participatory, human centered design to co-develop useful interventions, and 2) implementing and
evaluating interventions. The proposal also describes a 4-year project for developing a prototype care
transition medication safety intervention and generating early evidence on its usability and potential factors
influencing its future implementation.
Aim 1: Patient journey mapping—will be used to elucidate medication safety risks and contexts during the
hospital-to-home transition period. Journey maps will be used to capture and visually represent the medication
use experience of families across professional settings and boundaries. The output of this aim will inform
prototype design under Aim 2.
Aim 2: Participatory, human centered design to co-design a prototype medication safety intervention. Through
multiple, iterative co-design sessions involving healthcare workers and family caregivers, a team will design a
prototype medication safety intervention informed by journey maps from Aim 1, current literature, and
participant elicitations. The result will be a composite prototype ready for usability testing.
Aim 3: Will test usability of prototype intervention with healthcare workers and family caregivers. Additionally,
barriers and facilitators that may be anticipated during future prototype implementation will be explored. Taken
together, all 3 aims will yield a final, refined prototype intervention designed to improve medication use safety
during care transitions.
Future work will include a randomized controlled trial of the prototype medication safety intervention to
formally evaluate it effectiveness in preventing or reducing medication related harm as well as improving the
medication use experience of CMC and their family caregivers.

Public health relevance
PROJECT NARRATIVE Children with medical complexity (CMC) have a high risk of experiencing medication related harm but can benefit from interventions that involve their caregivers as co-designers. This award will support the candidate’s (1) training in participatory, human centered design and (2) skill development in implementation and evaluation research to design and test interventions fit for unique needs of CMC.